Early life factors, gene-environment interaction and eosinophilic esophagitis

SUMMARY
With this proposal and the future research supported by its findings, we propose to test the hypothesis that
early life, ante- and postnatal exposures are risk factors for eosinophilic esophagitis (EoE), particularly in
genetically susceptible individuals. The central hypothesis is that risk of EoE is determined by complex
interactions between early-life exposures and susceptibility genes with demonstrated functionality in gene and
immune regulation The underlying concept of this work it that early life, ante- and postnatal exposures – known
to disrupt colonization of gut microbiota and believed to alter immune development – are risk factors for EoE,
particularly in genetically-susceptible individuals. This study builds on early evidence we have generated from
single center, case control studies suggesting that certain early life exposures (antibiotic use in infancy,
preterm delivery, Cesarean delivery, neonatal intensive care unit admission, pet exposure and breastfeeding)
are associated with increased risk of EoE and that certain susceptibility genotypes (TSLP at 5q22 [rs3806932],
the LOC283710 and KLF13 region at 15q13 [rs4329885], and CAPN14 [rs6736278]), interact with early life
exposures to modify risk. The present study uses a population-based, case-control study with complete case
ascertainment of EoE cases to build on this early evidence. Specifically, the proposed research project
includes: Aim 1, a population-based registry-linkage study of early life factors and EoE for data collected
prospectively, using population-based registries to characterize cases and controls, measure primary
exposures, and potential confounders; Aim 2, a focused gene-environment interaction study informed by
previous research on susceptibility SNPs and early life factors associated with EoE; and Aim 3, an evaluation
of genetic load and genetic load in interaction with early life factors as a means of assessing genotype in
context of phenotypic heterogeneity in disease and identifying possible novel loci implicated in disease
pathogenesis. These analyses will not only provide evidence to address the aims outlined, but will also inform
future, consortium-based studies of gene-environment interaction in EoE. The research team includes experts
in pediatric epidemiology (Jensen), genetic epidemiology (Langefeld and Martin), EoE (Dellon), and
immunology and the genetics of EoE (Rothenberg and Kottyan). The research will bring together a unique set
of national and international resources and expertise.

Public health relevance
NARRATIVE Eosinophilic esophagitis is an increasingly common cause of upper gastrointestinal symptoms in children and adults; it is known to be immune-mediated, but the etiologic factors for disease are unknown. The reasons for the increase in EoE incidence are poorly understood, are not solely attributable to increased recognition and, based on preliminary evidence, may be driven by early life experiences. The proposed study aims to identify early life risk factors for the development of pediatric EoE and to assess whether these early life factors interact with underlying genetic susceptibility to increase risk for disease development.